Bioinformatics Core

ABSTRACT
The P01 Bioinformatics Core (PI - Thomas Carroll, BRC RU) will provide a centralized resource for all bioinfor-
matics analysis performed within this Food Allergy P01 and so will act to ensure synergy in the analysis, inte-
gration and interpretation of this data. As part of this Food Allergy P01, the Bioinformatics Core will provide ex-
pertise and interactive tools for the analysis of transcriptomes from gut epithelial, neuronal and immune cells
under food allergy conditions as well as in the analysis of uLIPSTIC imaging data. The Bioinformatics Core has
extensive experience in the analysis of all sequencing data types to be used within this P01 and have pre-es-
tablished high-throughput pipelines and graphical user interfaces (GUIs) for the analysis of this data. Working
with P01 researchers, the Bioinformatics Core will optimize pipelines for the data under interrogation and de-
velop new web accessible GUIs to allow all P01 researchers access to the data. For the analysis of the imag-
ing data, the P01 Bioinformatics Core will work with P01 researchers and the Victora laboratory at the Rocke-
feller University to develop best practices in the analysis of this data. The Bioinformatic Core PI, Thomas Car-
roll, has broad expertise in the analysis of bioinformatics data, having been an author on > 70 papers, and has
great experience in the management of bioinformatics cores and large-scale genomics projects such as the
GenSat project. Bioinformatics Core personnel will support differing aspect of this project and have many years
of experience in the analysis of bulk and single cell/nuclei RNA-seq, GUI design and data management. All
Bioinformatics Core members follow best practices in the capture of code and software environments and so
provide reproducibility in all analyses. With the team’s experience and expertise in the analysis of data to be
used in this project, the P01 Bioinformatics Core is well placed to meet all the needs of this Food Allergy P01.